A Trauma-Informed Intervention for Sexual Minority Men Recently Diagnosed with HIV

Project Summary/Abstract
Compared to the general population in the United States, people living with HIV (PLWH) show high rates of
trauma- and stress-related disorders and severe acute stress reactivity to events that are, diagnostically, not
considered traumatic. Trauma is highly correlated with depression, a robust predictor of antiretroviral treatment
(ART) non-adherence. Additionally, reporting a high number of recent stressful events is associated with ART
non-adherence. Despite Black sexual minority men (BSMM), particularly those under age 40, being
disproportionately affect by HIV and trauma and less likely to be linked to HIV care after diagnosis, BSMM remain
grossly underserved with respect to their mental health. Further, although interventions exist that address trauma
for PWLH, few HIV-related interventions emphasize the traumatic stress cycle and acute stress reactivity
immediately following an HIV diagnosis. To address the need for early mental health intervention immediately
after HIV diagnosis, in general, as well as the under-addressed mental-health needs of HIV+ BSMM (+BSMM),
in particular, we will develop and pilot-test a resilience-focused, trauma-informed intervention called, Resilience-
Based Intervention for Stress Reduction and HIV-Related Efficacy (RISE). RISE will be based on
approaches and techniques of Cognitive-Behavior Therapy (CBT) and the framework of Resilience Theory. It
will address trauma- and stress-related symptomology and acute stress reactivity within three months of an HIV
diagnosis to facilitate linkage to HIV care. The brief RISE will include six online sessions, a booster session, and
text messaging. Innovative commercial marketing techniques will be used to develop highly targeted messages
to supplement the CBT- and resilience-based approach of RISE. First, Aim 1 will involve formative research to
assess +BSSM's needs, preferences, and perceptions regarding their mental health and their engagement in
HIV care via in-depth interviews with +BSMM and service providers. Next, Aim 2 will include development of the
RISE intervention manual and digital health infrastructure. Tailored text messages and health-promotion
materials will be developed via in-depth interview-derived quantitative surveys with 50 +BSMM. The Aim will also
include an iterative process of intervention development, including focus groups with +BSMM and service
providers, respectively, and intervention theatre tests with 6 +BSMM. Finally, Aim 3 will consist of a randomized,
controlled pilot trial for feasibility (e.g., recruitment and enrollment rates, fidelity), acceptability (i.e., feedback
interview, satisfaction questionnaire), and preliminary efficacy (i.e., increased HIV care engagement, including
attending an HIV care appointment, antiretroviral treatment [ART] initiation, and ART adherence [primary
outcome]; reduced trauma symptoms, including intrusive experiences, avoidance, and hyperarousal [secondary
outcome]) with 40 +BSMM diagnosed within the past three months. Participants will be assessed at baseline,
post-intervention, and 6- and 9-month follow-ups post-baseline. We will develop and maintain a community
advisory board for consultation throughout the study.

Public health relevance
Project Narrative The National HIV/AIDS Strategy and the Ending the HIV Epidemic initiative emphasize: (1) achieving viral suppression among HIV+ people in order to reduce HIV transmissibility, particularly for disproportionately affected groups such as Black sexual minority men (BSMM), by retaining them in HIV care, and (2) addressing comorbidities and complications, which include mental health concerns such as trauma symptomology and severe acute stress reactivity. Despite the disproportionate impact of both HIV and traumatic stress on BSMM and the adverse effects of stress on engagement in HIV care, BSMM remain grossly underserved with respect to their mental health. To address these gaps, the proposed study will develop an intervention that will: (1) provide a brief, resilience-oriented, trauma-informed intervention that combines online sessions and highly tailored text-messaging to reduce participant burden and motivate clients between sessions, (2) provide preliminary treatment for HIV+ BSMM's unaddressed mental health needs, and (3) be embedded early in the HIV continuum of care immediately after diagnosis to facilitate linkage to and retention in HIV care.